Development of a RUNX1 modulator to slow cognitive decline in Alzheimer's disease

PROJECT SUMMARY
An estimated 6.9 million people over the age of 65 in the US are living with Alzheimer’s disease (AD),
experiencing debilitating memory loss and physical impairments. Novel therapeutic treatments beyond those
targeting amyloid beta (Aβ) are essential to address the immense universal burden of AD. Age-associated
microglial dysfunction and accumulation of senescent microglia are increasingly recognized as mediators of
mild cognitive impairment and AD. Thus, modulating microglial function in AD represents a distinct therapeutic
approach that may lead to safe and effective treatments to slow the progression and potentially prevent the
onset of AD. We hypothesize that the transcription factor RUNX1 is a driver of microglial dysfunction that
results in cognitive decline with age. We have developed RUNX1-targeting antisense oligonucleotides capable
of lowering RUNX1 expression both in murine primary microglia and in vivo in mice. The goal of this Phase I
proposal is to identify a lead RUNX1 ASO development candidate and demonstrate therapeutic potential of
RUNX1 ASOs for the treatment of AD. Specifically, we will: 1) conduct lead ASO therapeutic optimization to
improve the safety and potency profile, and 2) demonstrate efficacy in a mouse model of AD using molecular
biomarkers and behavioral endpoints. The proposed work will provide proof-of-concept for targeting RUNX1 as
a novel approach to slow the cognitive decline in AD.

Public health relevance
PROJECT NARRATIVE Additional therapeutics are needed to prevent or slow memory loss in late-onset Alzheimer's disease. The project will identify a lead candidate and generate preclinical in vivo data validating RUNX1 as a target for combating neuroinflammation in Alzheimer's disease using mouse models. Therapeutics reducing RUNX1 expression represent a novel approach to slow cognitive decline in Alzheimer's disease.